Guideline-Recommended Implementation of Pediatric Ambulatory Blood Pressure Monitoring (GRIP ABPM)

ABSTRACT
Dr. James T. Nugent is an Instructor of Pediatrics in the Sections of Pediatric Nephrology and General Pediatrics
at Yale School of Medicine. The goal of this K23 Career Development Award is to provide mentored training in
applying clinical research methods to support Dr. Nugent’s development into an independent physician-scientist
studying hypertension in children. Dr. Nugent’s scientific mission is to tailor cardiovascular disease prevention to
the needs of disproportionately affected populations. His prior work has leveraged electronic health records and
historical data to improve the care of children with hypertension in the inpatient and outpatient settings. To
become an independent physician-scientist, Dr. Nugent requires the support of this K23 award to achieve the
following training objectives: (1) methodologic expertise in implementation science, mixed methods, clinical
decision support, trial design, and cost-effectiveness analysis; (2) direct experience in prospective human
subjects research; and (3) structured professional development to lead a clinical research team. The scientific
objective of the planned research is to develop and test a multilevel implementation strategy to improve the
guideline-recommended use of ambulatory blood pressure monitoring (ABPM) in children and adolescents with
hypertension. Screening for hypertension in childhood is recommended to prevent long-term cardiovascular
morbidity and mortality. However, the diagnosis of hypertension in children is challenging due to the unreliability
of office BP measurement. Therefore, current pediatric guidelines recommend performing ABPM to diagnose
hypertension in children. Despite its superior accuracy, ABPM is not widely available in pediatric primary care,
and we have found that only 8% of US children with hypertension have ever completed this guideline-
recommended test. Practical and sustainable approaches are needed to implement guideline-based ABPM
outside the subspecialty setting. In Aim 1, we will characterize the barriers to and facilitators of ABPM utilization
among patients, primary care clinicians, hypertension specialists, and nurses. The results of the pre-
implementation assessment in Aim 1 will inform the design and evaluation of an implementation strategy in Aim
2 to promote the completion of guideline-recommended ABPM in pediatric primary care. This multifaceted
implementation strategy will have several key components, including electronic clinical decision support, the use
of a centralized ABPM service, and closed-loop communication of ABPM results and recommendations from the
hypertension specialist to the primary care clinician. In Aim 3, we will determine the costs associated with ABPM
implementation and compare the cost-effectiveness of different ABPM screening strategies in the general
pediatric population. Completion of these aims will inform an R01 to conduct a multicenter, cluster randomized
trial to further optimize and test the efficacy of a multilevel implementation strategy to increase guideline-based
utilization of ABPM across a national network of pediatric hypertension centers and referring primary care clinics.

Public health relevance
PROJECT NARRATIVE Screening for hypertension in children is an important strategy for the prevention of future cardiovascular disease. However, office blood pressure measurements are unreliable in children; thus, children with high blood pressure at the primary care office are often referred to the subspecialist to perform ambulatory blood pressure monitoring outside the clinic, resulting in delays in care, loss to follow-up, and clinical inertia. Given the rising prevalence of pediatric hypertension and limited access to ambulatory blood pressure monitoring, the objective of this proposal is to evaluate a multicomponent strategy to improve the guideline-recommended use of ambulatory blood pressure monitoring in the pediatric primary care setting, which has the potential to empower primary care clinicians to promptly diagnose and initiate treatment for hypertension.